Molecular Networks and Deep Learning for Targeted HIV Interventions among PWID

PROJECT SUMMARY
Meeting targets set to end AIDS by 2030 requires reaching all populations, particularly those with the highest
burden, such as people who inject drugs (PWID). PWID continue to experience some of the most explosive
HIV epidemics globally. Injection drug use is increasingly accounting for new HIV infections in both low- and
middle-income countries (LMICs) and countries that once saw notable declines in HIV incidence among PWID.
Even in countries with notable declines in HIV incidence among PWID, such as the United States, the rise of
prescription opioid use has resulted in increased heroin injection, increased overdose rates, and outbreaks of
HIV. Combating the HIV epidemic among hard-to-reach populations, such as PWID, requires targeted
approaches that consider multiple levels of risk that extend beyond individual-level factors alone. Looking at
HIV prevention through the lens of network science can allow us to study and address health disparities on a
social and structural level. Limited network studies among PWID have demonstrated that social and spatial
networks play a significant role in HIV transmission and may be further leveraged for targeted intervention
approaches. However, network data can be challenging to enumerate and analyze, and additional network
tools and analytic approaches are needed to take full advantage of the power of social networks for HIV
prevention efforts. Given the challenges of collecting data on social connections among PWID, by finding
proxies for network data or ways to impute networks we can harness these connections to interrupt HIV
transmission. Network-based interventions may not only be more effective at interrupting community
transmission than individual-level approaches but could represent the most cost-efficient approach as well –
which is crucial given the budgetary and resource constraints programs often face.
This study leverages a rare set of longitudinal social and spatial network data along with detailed individual-
level data and HIV sequences from over 2,500 PWID in New Delhi, India followed from 2016-21. It aims to
explore the use of machine learning and viral phylogenetics as a potential avenue to circumvent network
enumeration challenges and produce new analytical strategies to monitor epidemics and model the most
effective and resource-efficient intervention approach in a city. In practice, this affords the development of
network models that simulate the effect of various network-based intervention strategies on HIV incidence and
could be used to inform a wide array of social, behavioral, and pharmacologic interventions. Making network
data more accessible can lead to new HIV prevention approaches that guide officials in focusing limited
resources for the greatest impact and can provide a greater understanding of the epidemic dynamics.

Public health relevance
PROJECT NARRATIVE Network science can allow us to study and address health disparities on a social and structural level, and network-based intervention strategies represent a powerful approach for combatting HIV epidemics – particularly among substance using populations – but additional network tools and analytic approaches are needed to take full advantage of the power of social networks. This study will evaluate the use of machine learning and viral phylogenetics as a potential avenue to overcome data collection limitations, better analyze network data to monitor epidemics, and model the most effective and resource-efficient intervention strategies. It is innovative in its ability to make targeted network-based interventions more accessible and widespread and can lead to new HIV prevention approaches that guide public health officials in focusing limited resources for the greatest impact, as well as provide a greater understanding of the current and future epidemic dynamics.